Longitudinal EEG and Environmental Trajectories Leading to ADHD and Disruptive Behaviors from Infancy to Preschool

Project Summary
Attention deficit hyperactivity disorder (ADHD) and disruptive behaviors (DBs) affect up to 9% of children.
Under-diagnosis and under-treatment of ADHD and DBs disproportionately affect children with socioeconomic
stress and disadvantage, and lead to early childhood morbidities (e.g., preschool expulsion, learning
difficulties) and later adult adversity (e.g., mental health disorders, unemployment, suicide). Identification of
infants and toddlers at risk for early ADHD and DBs, especially in families with socioeconomic disadvantage,
would allow for provision of preventative interventions to minimize the negative impacts of these symptoms.
Additionally, improved understanding of the neurodevelopmental pathways to ADHD and DBs would maximize
the impact of developmentally and individually targeted preventative interventions.
Accordingly, this study will leverage a large, currently enrolling NINDS funded sample of low-resourced, racially
and ethnically diverse infants seen in an urban primary pediatric care clinic, for whom EEG, developmental and
environmental data are already being collected longitudinally from 4- to 24-months old. The current
investigation will collect EEG and ADHD/DB-focused measures at an additional time point (3- or 4-year well-
child visit) in order to measure ADHD and DB outcomes in preschoolers. Our first aim is to characterize
neurodevelopmental trajectories leading to early ADHD and DB symptoms using repeated EEG in very
young children. Second, we will utilize parent survey data and medical record abstraction collected repeatedly
across infancy and early childhood to integrate effects of social determinants of health (e.g., socioeconomic
status, caregiver well-being, access to basic needs) into longitudinal models of brain development and
behavioral regulation.
Results from this study will inform future development of scalable and objective tools to identify children with
increased likelihood of ADHD and DBs across resource settings, and facilitate development of interventions
that use resources efficiently. Importantly, longitudinal characterization of this large cohort will provide greater
understanding of what neurophysiological and environmental factors influence brain and behavioral
development, and when the brain may be most sensitive to intervention.

Public health relevance
Narrative Earlier identification of children at increased likelihood of ADHD and disruptive behavior symptoms would facilitate provision of preventative interventions and reduce negative functional impacts on child mental health, academic achievement and family stress. This application proposes to extend a currently enrolling longitudinal NINDS R01 study collecting EEG, demographic, and developmental data from infants from 2-24 months old in a large pediatric primary care clinic that disproportionately serves under-represented groups, with the goal of identifying children with elevated ADHD symptoms and disruptive behaviors at study visits completed at 3- or 4-years-old.